Therapeutic Strategies to Prevent Small Cell Lung Cancer Histological Transformation

Project Summary
Histological transformation is a common mechanism of resistance to EGFR inhibitors as 5-25% EGFR-mutant
lung adenocarcinomas (LUAD) transform into either small cell lung cancer (SCLC) or a squamous cell carcinoma
(SCC) in response to EGFR tyrosine kinase inhibitors. LUAD patients with RB1 and TP53 inactivation are at a
much greater risk (50X) for SCLC transformation suggesting therapeutic strategies to block SCLC transformation
may be particularly beneficial for EGFR-Mutant LUADs with RB1 and TP53 inactivation. Due to a paucity of
clinical samples and model systems, the mechanistic basis that drives LUAD to SCLC transformation is not well
understood nor are there effective therapeutic strategies. EED is an indispensable subunit of the Polycomb
Repressive Complex 2 (PRC2) whose activity increased during LUAD to SCLC transformation in human lung
cancers. My preliminary data shows that inactivation of EED promotes SCLC to LUAD transformation in an
autochthonous CRISPR-based SCLC genetically engineered mouse model (GEMM) demonstrating that EED is
necessary for SCLC neuroendocrine phenotype. Therefore, my central hypothesis is that EED is necessary for
LUAD to SCLC transformation and EED inactivation will block SCLC transformation induced by EGFR inhibitors.
Specific Aims: 1. Determine Mechanisms by which Eed Inactivation Promotes SCLC to LUAD Histological
Transformation; 2: Determine how Rb1 Inactivation Mediates EGFR-mutant Lung Adenocarcinoma to SCLC
Transformation; 3: Determine if EED Inhibition is a Druggable Therapeutic Strategy to Block EGFR-mutant LUAD
to SCLC Transformation. In Aim 1, transcriptomic and epigenomic profiling will be used on EED-isogenic SCLC
tumors to determine direct mechanisms by which loss of EED promotes histological transformation from SCLC
to LUAD. For Aims 2 and 3, I generated a novel CRISPR-based EGFR-mutant LUAD to SCLC transformation
GEMM with Rb1/Trp53 inactivation which I will use to uncover how Rb1 loss mediates SCLC transformation
(Aim 2) and to determine whether Eed inhibition blocks SCLC transformation (Aim 3). This proposal will lay the
preclinical foundation for EED inhibition as a therapeutic strategy to combat LUAD to SCLC transformation.
My long-term goal is to establish myself as an independent researcher with the focus on lung cancer drug
resistance. My research bridges multiple disciplines to study lung cancer drug resistance and requires a unique
skill set and in-depth knowledge of lung cancer, drug resistance, epigenetics, bioinformatics, and mouse
modeling. The K99/R00 award will help in achieving my goal, as I will be guided towards becoming an
independent investigator under the guidance of extremely well-established scientists such as Drs. Matthew Oser
and Pasi Janne (thoracic oncology), Dr. Carla Kim (mouse modeling), Drs. Matthew Freedman (epigenetics),
and Himisha Beltran (lineage plasticity and translational science). This proposal will identify a potential
therapeutic strategy to overcome lung cancer drug resistance and will seed a research program that leverages
a deep understanding of epigenetics and mouse modeling to help to develop novel cancer therapies.

Public health relevance
Project Narrative Small cell lung cancer (SCLC) transformation is a mechanism of drug resistance in lung cancer and correlates to elevated activity of the PRC2 histone methyltransferase complex. There are currently no treatment strategies to combat SCLC transformation. This proposal will elucidate the role for the PRC2 complex in SCLC transformation and test whether clinical grade inhibitors of the PRC2 complex can be used to block SCLC transformation as a therapeutic strategy for EGFR-Mutant lung cancer.